Chemistry Core

Project Summary
The ability of microbes, especially bacteria, to produce biologically active molecules that can form the basis of
therapeutic agents to confront important human pathogens forms the overall premise of this CETR application.
The microbial producers will be symbiotic bacteria from a variety of niches. The assays that will lead to the
discovery of potential therapeutic agents will focus on multidrug resistant Gram-negative bacteria and systemic
fungal pathogens. The Chemistry Core will be responsible for converting the activity discovered in biological
assays into purified active molecules with known structures in sufficient amounts that secondary functional
assays, structure-activity studies, and target identification can be addressed. This overall goal will be
accomplished with four tasks, which are described in much greater detail in a later section of the proposal.
Task 1: Produce symbiotic microbe metabolite fractions for dereplication and in vitro efficacy and safety
testing.
Task 2: Scale-production of promising fraction for in vivo testing and structural elucidation.
Task 3: Purify and structurally characterize the active molecule/s.
Task 4: Large-scale production for advanced in vivo PK/PD and mechanism of action determination.

Public health relevance
Relevance The Chemistry Core will translate the functional discoveries identified in the preliminary assays into characterized molecules that can be studied and further developed into therapeutic agents.